Clinical Implications of Natural Killer-derived exosomal miRNAs in Neuroblastoma

PROBLEM. Pediatric tumors represent a very heavy social and economic burden with profound emotional
involvement not only for the directly affected children but also for their family and friends. Within pediatric tumors,
neuroblastoma (NB) is of particular relevance, since it is the most common solid cancer in children outside of
the skull and it still kills about 40% of patients diagnosed with the most aggressive forms. Therefore, there is a
clear need to improve the treatment for this deadly disease. Development of more potent immunotherapies could
improve outcome for these patients. PREMISE. Natural killer (NK) cells, especially when “activated” (aNK cells)
mediate direct cytotoxicity and antibody-dependent cellular cytotoxicity (ADCC). All cell types release
extracellular vesicles called exosomes that contain biologically active components (proteins, DNA, mRNA, and
non-coding RNAs including miRs) that can be delivered to recipient cells and influence their functions. Exosomes
released by aNK cells, could increase the efficacy of chemoimmunotherapy in NB. Little is known about human
aNK cell-derived exosomes, their therapeutic potential and role as biomarkers of response to
chemoimmunotherapy in NB. Our group was the first to show that microRNAs (miRs) in aNK-derived exosomes
are able to kill NB cells. OUR DATA. We can propagate and activate blood NK cells from normal donors and
patients with NB using K562-mbIL21 artificial antigen presenting cells (aAPC) plus IL-2. We discovered that
these aNK cells release large quantities of exosomes and that purified aNK exosomes are cytotoxic for NB cell
lines. We also have preliminary evidence that aNK-derived exosomes contain miRs that contribute to the
cytotoxic effect of aNK-exosomes. We also observed that children affected by NB responsive to
chemoimmunotherapy, present markers of aNK activation in their blood. We hypothesize that aNK-derived
exosomes kill NB cells through the exosomal transfer of MYCN-, AURKA-, TGFBR1- and TGFBR2-targeting
miRs, and that these miRs can be exploited to develop an anti-tumor effect and implement the efficacy of
chemoimmunotherapy for NB patients. We also hypothesize that specific circulating and exosomal miRs can be
exploited as biomarkers of response to chemoimmunotherapy in children affected by NB. These hypotheses will
be tested in the following Specific Aims: 1) To study cytotoxicity mechanisms and therapeutic efficacy of aNK-
derived exosomes alone and combined with chemoimmunotherapy in NB; 2) To assess association of NK-
exosomal miRs, circulating RNAs, and gene expression profiles with response in patients treated on
chemoimmunotherapy regimens. SUMMARY. We focus upon a completely new immunotherapeutic strategy
using human miR-enriched aNK exosomes. The results of this study will provide important information for
producing highly cytotoxic aNK exosomes which could potentiate efficacy of existing chemoimmunotherapy. This
study will also identify new exosomal RNA cargo able to stratify neuroblastoma patients for response to
chemoimmunotherapy.

Public health relevance
PROJECT NARRATIVE This proposal intends to study the role of microRNAs (miRs) contained in the exosomes of Natural Killer (NK) cells in the cytotoxic activity of these vesicles against neuroblastoma (NB) and in their ability to synergize with chemoimmunotherapy. The study will identify the mechanism through which aNK-derived exosomal miRs elicit a cytotoxic effect on NB cells, will explore this mechanism to increase efficacy of current chemoimmunotherapy for the treatment of NB, and will correlate circulating and exosomal miRs to response to chemoimmunotherapy. The results of this study will help identify new strategies to treat NB (and possibly other types of cancer) and will ultimately lead to increased number of saved lives of cancer patients.